ATLAS-BASED SEGMENTATION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This project is just starting, although, the aim is to develop automatic atlas registration algorithms. Specifically the project will focus on aligning deformed mouse brains to a healthy atlas average.